Mechanisms of pigment cell maturation and subtype specification during zebrafish stripe pattern formation

PROJECT SUMMARY/ABSTRACT
There are numerous examples of self-assembled patterns in biology, but most research effort has focused on
only a few systems (syncytial patterning in Drosophila, adhesion-based sorting of heterogeneous cell
populations, gradient-induced specification of homogeneous populations). The goal of this proposal is to
identify molecular mechanisms that regulate pigment pattern formation in adult zebrafish. Adult zebrafish
pigment cells differentiate from neural crest-derived progenitors, and reciprocal interactions between pigment
cells are essential for stripe pattern formation. One class of pigment cells, iridescent iridophores, is responsible
for establishing and reiterating the pattern of dark stripes and light interstripes. Two iridophore subtypes occur
in zebrafish: “loose,” mesenchymal-like iridophores that associate with melanophores in dark stripes, and
“dense” epithelial-like iridophores of light interstripes that drive orange xanthophore differentiation within the
interstripes, while also setting the positions of adjacent stripes. The mechanisms that specify loose and dense
iridophore subtypes have not been determined. In this proposal, Aim 1 focuses on an innovative hypothesis to
account for subtype specification via interactions among iridophores, melanophores and the tissue
environment involving two candidate signaling pathways. Aim 2 addresses essential roles for a cell-
autonomous factor, identified by forward genetics, in promoting iridophore maturation and, thereby, the
essential interactions between iridophores and other pigment cells underlying pattern formation. Approaches
will range from classical genetic analysis to time-lapse imaging, and from gene expression analysis in situ to
single cell RNA-Sequencing. These studies will provide insights into iridophore differentiation and
morphogenesis that will augment our understanding of the genetic basis of cellular behaviors during the
dynamic self-assembly of tissue patterns.

Public health relevance
PROJECT NARRATIVE The neural crest gives rise to diverse cell lineages that contribute to craniofacial cartilage and bone, peripheral neurons and glia, skin pigmentation and other adult features; abnormal development of neural crest-derived cells can lead to numerous health problems including deafness, bowel obstruction, heart abnormalities, and skin and facial deformities that can have devastating consequences for affected individuals. The proposed research using a highly tractable system will advance our understanding of vertebrate development and the complex interactions between cells that are required for generating distinct features of adult tissues and organs.